Leadership Administrative Core

The Brigham and Women’s Hospital (BWH)/Harvard Medical School (HMS) Reproductive
Outcomes of Stress and Aging (ROSA) SCORE focuses on stress exposures and how neural regulation transmits stress to worsen the health of women across and after menopause. The overarching scientific goal of the ROSA SCORE renewal proposal is to investigate the impact of stress exposures occurring at both the individual and neighborhood level on core menopausal vasomotor symptoms (VMS) and sleep, mood, memory and cognition problems. Disturbances in these neurocognitive domains greatly disrupt the health and activities of women during this pivotal reproductive health transition, potentially accelerating cognitive aging and reflecting a risk profile for dementia, a neurodegenerative disorder more common in women. The Leadership Administrative Core (LAC) will continue to lead and partner with the Project and Core Leads and research staff of the ROSA SCORE to ensure that the scientific and administrative objectives are achieved. The main goals of the LAC are to 1) provide scientific and programmatic leadership for the BWH/HMS ROSA SCORE; 2) ensure centralized administration and organizational management of the Center; and 3) maximize the ROSA SCORE’s impact across BWH/HMS, the national SCORE Consortium, and related academic programs. To achieve these objectives, the LAC will continue to facilitate internal coordination and communication within the ROSA SCORE, enrich external engagement between our Center and the national SCORE Consortium, and enlist the input of the two established and committed advisory groups – one internal and the other external to the institution – to advise on the direction of the Center’s scientific and programmatic
activities. The LAC will continue to collaborate with the Career Enhancement Core (CEC) to review and issue the Pilot Project Awards and Travel Fellowship Awards to achieve the Center’s educational objective of catalyzing research on midlife women’s neurocognitive health. The LAC will leverage the robust institutional and philanthropic resources as well as the educational and administrative infrastructure available from the BWH Connors Center for Women’s Health Research, the leading women’s health research program at BWH and HMS. Working closely with the renowned ROSA SCORE investigators and integrating across the Connors Center and synergistic research programs focused on women’s brain health (including dementia) at BWH and HMS, the LAC will ensure that the impact of the ROSA Center locally and across the SCORE Consortium is sustained and amplified. Through these pivotalThe Brigham and Women’s Hospital (BWH)/Harvard Medical School (HMS) Reproductive
Outcomes of Stress and Aging (ROSA) SCORE focuses on stress exposures and how neural regulation transmits stress to worsen the health of women across and after menopause. The overarching scientific goal of the ROSA SCORE renewal proposal is to investigate the impact of stress exposures occurring at both the individual and neighborhood level on core menopausal vasomotor symptoms (VMS) and sleep, mood, memory and cognition problems. Disturbances in these neurocognitive domains greatly disrupt the health and activities of women during this pivotal reproductive health transition, potentially accelerating cognitive aging and reflecting a risk profile for dementia, a neurodegenerative disorder more common in women. The Leadership Administrative Core (LAC) will continue to lead and partner with the Project and Core Leads and research staff of the ROSA SCORE to ensure that the scientific and administrative objectives are achieved. The main goals of the LAC are to 1) provide scientific and programmatic leadership for the BWH/HMS ROSA SCORE; 2) ensure centralized administration and organizational management of the Center; and 3) maximize the ROSA SCORE’s impact across BWH/HMS, the national SCORE Consortium, and related academic programs. To achieve these objectives, the LAC will continue to facilitate internal coordination and communication within the ROSA SCORE, enrich external engagement between our Center and the national SCORE Consortium, and enlist the input of the two established and committed advisory groups – one internal and the other external to the institution – to advise on the direction of the Center’s scientific and programmatic
activities. The LAC will continue to collaborate with the Career Enhancement Core (CEC) to review and issue the Pilot Project Awards and Travel Fellowship Awards to achieve the Center’s educational objective of catalyzing research on midlife women’s neurocognitive health. The LAC will leverage the robust institutional and philanthropic resources as well as the educational and administrative infrastructure available from the BWH Connors Center for Women’s Health Research, the leading women’s health research program at BWH and HMS. Working closely with the renowned ROSA SCORE investigators and integrating across the Connors Center and synergistic research programs focused on women’s brain health (including dementia) at BWH and HMS, the LAC will ensure that the impact of the ROSA Center locally and across the SCORE Consortium is sustained and amplified. Through these pivotal leadership roles and in partnership with our Center’s expert investigators and research educators, the LAC will continue to advance critical knowledge on the impact of stress on neurocognitive performance in aging women.
leadership roles and in partnership with our Center’s expert investigators and research educators, the LAC will continue to advance critical knowledge on the impact of stress on neurocognitive performance in aging women.

Public health relevance
NARRATIVE The Leadership Administration Core (LAC) will oversee the scientific agenda and administration of the research Projects, Career Enhancement Core, and Sleep Resource Core of the Brigham/Harvard SCORE Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes, called the Reproductive Outcomes of Stress and Aging (ROSA) Center. The LAC will also ensure engagement of the ROSA Center with the broader national SCORE Consortium and support investigators to achieve their specific aims. Our overarching goals are to advance our understanding of stress exposures and neural regulation of reproductive aging health outcomes and catalyze the growth of interdisciplinary and translational women’s health research.